Voluntary National Retail Food Regulatory Program Standards Self-Assessment & Verification Audit Online Workshop

Project Abstract
The National Environmental Health Association (NEHA), a 501(c)3 nonprofit organization, is
pleased to submit an application for funding assistance under the U.S. Food and Drug
Administration (FDA) Support for Conferences and Scientific Meetings (R13 Clinical Trial Not
Allowed), FOA Number: PAR-19-306.
Since 2016, NEHA has been working to support retail food safety professionals by developing
resources and training for regulations and standards.
NEHA proposes to apply awarded funding towards three projects related to an online workshop
series that supports State, Local, Tribal, and Territorial (SLTT) agencies’ Self-Assessment and
Verification Audit process, which in turn assists them in their conformance with FDA’s Voluntary
National Retail Food Regulatory Program Standards (VNRFRPS, henceforth Retail Program
Standards). These projects will serve approximately 900 Retail Program Standards enrollees and
will include continuous improvement updates to existing content to align with updates to the Retail
Program Standards, development of an entry-level course for professionals new to the Retail
Program Standards, and production of a risk-based retail food safety inspection film.

Public health relevance
Project Narrative NEHA proposes to apply awarded funding towards three projects related to an online workshop series that supports State, Local, Tribal, and Territorial (SLTT) agencies’ Self-Assessment and Verification Audit process, which in turn assists them in their conformance with FDA’s Voluntary National Retail Food Regulatory Program Standards (VNRFRPS, henceforth Retail Program Standards). These projects will serve approximately 900 Retail Program Standards enrollees and will include continuous improvement updates to existing content to align with updates to the Retail Program Standards, development of an entry-level course for professionals new to the Retail Program Standards, and production of a risk-based retail food safety inspection film.